Advanced Training in Urologic Oncology

Urologic cancers impose a significant burden on the health of Americans. In 2023, an estimated 68,000
individuals will die from cancers that fall under a urologist’s care, a figure that accounts for 11% of all cancer
mortality. These numbers are expected to rise over the next decades as the overall population ages. At the
same time, the pace of innovation and discovery in translational science and health services research in the
area of cancer continues to accelerate. These combined factors require a well-prepared, research-oriented
work force that is capable of asking and answering clinically relevant scientific questions that have potential to
be translated into impactful discoveries. A number of sources suggest that today, only a small fraction of
urologic surgeons possess such skills. The primary goal of this T32 renewal application is to prepare urology
trainees for an academic career in urologic oncology by providing a comprehensive training program
comprised of mentored training options in either translational laboratory science or health services research.
Investigative themes of the program will be based on the research focus and expertise of a group of multi-
disciplinary externally funded faculty members in the Rogel Comprehensive Cancer Center at the University of
Michigan and composed of individuals from the Departments of Urology, Internal Medicine, Pathology, Surgery
and Pharmacology- all in the University of Michigan Medical School as well as faculty from the University of
Michigan School of Public Health. This proposal is a renewal application to train 4 postdoctoral fellows per
year. The major objective of our Advanced Training in Urologic Oncology program is to prepare individuals for
research and teaching careers in the field of academic Urologic Oncology. Graduating urology residents having
an M.D. or M.D./PhD. degree will be eligible. The program is structured around a research project supervised
by both research and methods mentors as well as an interactive and informative conference series and a
required core curriculum that includes specific graduate level courses that may lead to a Master’s degree.
Each trainee will choose between 1 of 2 tracks: translational laboratory science or health services research.
The goals of the program are to ensure that trainees: 1) design, implement, analyze and report a research
project, 2) obtain formal instruction on fundamental research methods and 3) gain instruction on either
fundamental principles of cancer biology (translational science track) or essential elements of conducting
health services research (health services track). There will be a special emphasis on formulating and testing
hypotheses that address clinically important questions. Additional training in the effective communication of
scientific results as well as grant preparation will be provided to all trainees. The long-term goal of our program
is to prepare trainees for independent careers in academic urologic oncology.

Public health relevance
Project Narrative The goal of the Advanced Training in Urologic Oncology program is to provide MD or MD/PhD urologic oncology fellows the skillset to pursue independent academic careers in cancer-focused research. Graduates of this program will contribute to the advancement of knowledge in the prevention, diagnosis and treatment of cancer.